Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The mission of the Southern California Environmental Health Sciences Center (SCEHSC) is to develop the
scientific knowledge base, investigator teams, and community engagement needed to reduce the burden of
diseases and disability from environmental impacts. The SCEHSC research base is comprised of $35,943,146
in annual direct NIH funding, $6,272,429 from NIEHS. The Administrative Core, led by the SCEHSC Director in
consultation with the Executive, Internal Advisory and External Advisory Committees, supports and integrates
all scientific and programmatic functions of the SCEHSC.
The goals of the Administrative Core are to: (1) coordinate and integrate SCEHSC enrichment activities,
including the seminar series, workshops and symposia, working groups, and retreats; (2) facilitate access to
SCEHSC Facility Core services; (3) recruit new environmental health sciences investigators with outstanding
ability and foster their career development; (4) promote cutting-edge interdisciplinary research opportunities; (5)
advance multidirectional engagement of communities and investigators; and (6) comprehensively evaluate the
performance of all SCEHSC components. The Administrative Core supports the Pilot Projects and Career
Development Programs and provides infrastructure for the Community Engagement Core and three Facility
Cores. The Administrative Core oversees evaluations of SCEHSC progress, membership review, and leadership
succession for the SCEHSC Director and other key leadership roles.